Enhancing Pathogen-Specific Memory CD8+ T cell Responses In Vivo

Abstract
Memory CD8+ T cells are essential adaptive effector cells of immune defenses because they are extremely
efficient at sensing intracellular pathogens and tumors. The chief effector feature of CD8+ T cells is their ability
to recognize and kill infected and “abnormal” cells but they also produce multiple effector cytokines and
chemokines that contribute to orchestrate protective immune responses. The cellular and molecular
mechanisms by which memory CD8+ T cells in vaccinated hosts are reactivated and mediate protection in vivo
are not well understood. Answering this question has the potential to lead to novel strategies to harness or
redirect the power of CD8+ T cells to the benefit of the host in many therapeutic contexts. Over the years, using
mice immunized with the intracellular bacterium Listeria monocytogenes (Lm) as model, we have contributed
to show that during recall infection, vaccine-induced memory CD8+ T cells quickly sense sets of inflammatory
cytokines released from various antigen-presenting cells (APCs), which initiate a rapid effector program in the
memory CD8+ T cells. This includes notably the secretion of the potent immunomodulatory cytokine IFNγ which
further signals and activates microbicidal functions inside phagocytes, a necessary process for efficient
protection of vaccinated hosts. More recently, during this funding period, we further established that, in addition
to IFNγ, a set of three chemokines, CCL3, CCL4 and XCL1, produced concomitantly by the memory cells in
response to cognate antigen (Ag) stimulation, are also required to achieve vaccinated host protection. We
further demonstrated that these processes are spatially and temporally regulated, and that memory CD8+ T
cells arrest in innate clusters of monocytes, and act as “catalysts” of their microbicidal effector functions. The
next step of this work proposes to understand i) the genetic and epigenetic circuitry of cognate Ag-driven
reactivation of the memory CD8+ T cell in vivo, ii) the chemotactic mechanisms coordinating the early Ly6C+
monocytic response and iii) the roles of the IFN-induced guanylate binding protein 1 (GBP1) in monocytes
effector response. We use state of the art single cell approaches, intravital imaging, lentiviral engineering and
new reporter/conditional mouse models to investigate these questions. We anticipate that successful
completion of the proposed work will have a broad impact in the field of T cell biology, and vaccines, and
potentially important therapeutic implications.

Public health relevance
Public Health relevant statement This project has the potential to improve T cell therapies. Specifically, the proposal focuses on populations of white blood cells (leukocytes) that are induced upon vaccination of individuals and can protect against microbial infections and tumors. These cells are cytotoxic (CD8+) lymphocytes, and become long-lived upon vaccination, therefore are called 'memory' lymphocytes. They can express multiple functions that are important to protect the host against infectious microbes and to kill tumor cells. We studied and discovered that these cells protect vaccinated host by very precisely orchestrating the effector response of other leukocytes. We propose in this proposal to pursue our dissection of how they achieve such efficient elimination of invading microbial pathogens in vivo with the goal of designing novel immune therapies.